Bridging Basic and Translational Science in Cardiovascular Disease

ABSTRACT
This proposal requests NHLBI support for the Scientific Sessions meeting presented by the Council on Basic
Cardiovascular Sciences (BCVS) of the American Heart Association (AHA). This meeting has become the “go
to” meeting for basic and translational cardiovascular sciences by providing opportunities for established and
emerging investigators to present their work and receive constructive feedback. The meeting in 2022
represents the seventeenth consecutive annual conference. Funding for BCVS Scientific Sessions from
National Heart, Lung and Blood Institute (NHLBI) has been secured for 15 of the last 16 years. The BCVS
summer conference is entitled “Bridging Basic and Translational Science in Cardiovascular Disease”. In
2021, our virtual conference was attended by more than 700 investigators from around the world. We sense
an urgent need for our community to hold an in-person meeting in 2022 to help facilitate the careers and
networking opportunities for young investigators. The meeting is scheduled for July 25-28, 2022 and will begin
on a Monday and run through Thursday. We expect that we will be able to hold an in-person meeting as well
has have virtual content (hybrid meeting) for those who cannot attend in-person. The conference will highlight
basic cardiovascular research with implications for cardiovascular health and disease. There will be
approximately 18 scheduled sessions that include a mix of established and emerging investigators. The
keynote address will be given by Dr. Leslie Leinwand. There is a specific session for those in the early career
phase. We will host special sessions for networking including interactions with journal editors and staff. We
will also include the Women in Science networking event. At every step, we focus on diversity and inclusivity
to promote the very best cardiovascular science. This R13 proposal is designed to provide support to young
investigators to enable their participation in the meeting as presenters either in oral or poster format. The
primary organizers are Drs. Pilar Alcaide and Sumanth Prabhu. The Program Committee (12 members)
includes the past program co- chairs and a diverse leadership (both US and international) drawn from the
many disciplines encompassed by BCVS. The AHA will continue to provide its outstanding administrative
support with dedicated staff for the logistics of the conference. We fully anticipate that this team will coordinate
an exceptional 2022 BCVS conference.

Public health relevance
NARRATIVE This award will support the summer meeting for the Basic Cardiovascular Sciences Council of the American Heart Association. The purpose of this meeting is to allow scientists to exchange information on the basic mechanisms of heart disease to help stimulate collaborations and new investigation. We also promote the careers of emerging scientists and trainees.